ROS Signaling in Wound Healing vs Tissue Repair

Project Summary/Abstract
Proper wound healing is critical following surgery and injury, while compromised healing is a
factor in diseases such as diabetes, obesity, tobacco abuse, and malnutrition. As well, tissue
restoration after healing is limited, such that most repair leads to scar formation and loss of
function. With millions affected and billions in associated care costs yearly, impaired wound
healing, chronic wounds and fibrosis-related diseases represent a critical health burden. Data
reveals that the presence of reactive oxygen species (ROS), byproducts of aerobic metabolism
containing oxygen that are highly reactive, are critical to wound healing outcomes. ROS are also
necessary for cell signaling and play a role in host defense and injury signaling. But the current
evidence is contradictory, suggesting both positive (required for repair and immune recruitment)
and negative (promoting cell damage) roles for ROS. Furthermore, it is not clear whether wound
healing and regeneration are separable processes. Our preliminary data suggests that there are
different wound-specific and regenerative-specific ROS signaling pathways and demonstrates the
usefulness of planarians to parse the roles of ROS in tissue repair. While all multicellular
organisms possess wound responses and repair mechanisms, the signaling that promotes healing
and regeneration versus scarring remains a mystery. This proposal’s long term goal is to
understand how ROS signaling may be manipulated to regulate both wound healing and tissue
repair, identifying new targets for treatment and refining current therapies for better patient
outcomes. This proposal’s objective is to identify differences in ROS levels and signaling that switch
injury-induced ROS responses from control of wound healing to tissue repair. We have two
hypotheses: 1) that distinct ROS-initiated signaling pathways regulate wound healing versus tissue
repair, and 2) that the level and timing of ROS present at the wound site determines whether
wound healing or regrowth occurs. These will be tested with two specific aims: AIM 1) to identify
wound-only versus regenerative-specific expression of ROS-mediated genes, detecting any epistatic
interactions; and AIM 2) to test the effects of different ROS levels on regeneration (proliferation
and tissue growth) and wound healing (actin-mediated reepithelization). In alignment with the
AREA mechanism, this work is designed to be completed mainly by undergraduate students—in
order to foster future independence and train them in common techniques (such as microsurgery,
cloning, in situ hybridization, immunohistochemistry, and RNA interference). These studies will
advance our understanding of impaired wound healing and fibrosis, and uncover fundamental
principles of how ROS is utilized during repair.

Public health relevance
Project Narrative The presence of unstable forms of oxygen (reactive oxygen species) are known to have large consequences on wound healing and regenerative outcomes. But it is still not well understood how the same oxygen species regulate these two different processes, even though millions are affected each year by poor wound healing and an inability to restore functional tissue. This project seeks to identify the genes and signaling pathways downstream of reactive oxygen species that control wound healing versus tissue repair, in order to identify new targets for treatment to promote proper healing after injury, surgery, and disease.